Real time speech enhancement/noise reduction for the hearing impaired

PROJECT SUMMARY/ABSTRACT
The current commercialization effort is aimed at solving the number one auditory complaint of people with hearing
loss. Whereas modern hearing devices (hearing aids and cochlear implants) generally provide good speech
understanding in quiet environments, users typically struggle to understand speech when background noise is
present. Accordingly, effective noise reduction (one that allows good speech intelligibility) is the number-one
requested feature by users of hearing devices. A long-sought solution involves a single-microphone algorithm,
one in which the speech and noise are picked up by the same single microphone, capable of removing noise
and improving speech understanding. The single-microphone solution is desirable because it is not subject to
the constraints of multi-microphone systems (e.g., beamforming). The current AI revolution finally allowed such
an algorithm, after 60 years of failed efforts. The initial demonstration of AI-based noise reduction was produced
by the current scientific advisor. It allowed large improvements in speech understanding, but it was constrained
to only the conditions it was trained on. The decade of scientific investigation that followed allowed the barriers
standing between the initial demonstration and a real-world capable system to be overcome. The current
development is focused on translating these scientific advances into a commercial product capable of removing
background noise and restoring speech understanding. We will implement state-of-the art neural networks to
perform noise reduction on the most common consumer portable device, the Apple iPhone. This platform has
vast computational and battery power relative to ear-worn technology and is therefore capable of supporting
relatively large and powerful networks. The result will be a software application capable of either (i) operating
independently using earbuds or (ii) integrating with existing hearing technology (e.g., Apple Made for iPhone
Hearing Aids). Neural networks will be broadly trained so that they can operate effectively on any voice and in
any noisy environment. They will be implemented in a manner that allows real-time operation at a predetermined
overall latency. Guided by these latencies, the parameters of the neural network will be manipulated to produce
the most highly and broadly effective implementations. These implementations will be assessed using commonly
employed objective metrics to establish their ability to remove background noise and improve predicted speech
intelligibility and sound quality. Using test speech and noises not employed during network training, the real-
time system will be evaluated using extended short-time objective intelligibility (ESTOI) and perceptual
evaluation of speech quality (PESQ). Preliminary studies indicate that the system is capable of large
improvements in predicted speech understanding, along with high speech quality, in real-time, and for essentially
any listener in any noisy environment. The current development effort therefore has the potential to improve
health and quality of life for millions of Americans by bringing to market a solution to arguably our most significant
and one of our most intractable problems.

Public health relevance
PROJECT NARRATIVE Poor speech understanding when background noise is present represents the primary auditory complaint of people with hearing loss. The current development effort will result in an AI-based noise-reduction system capable of improving speech understanding in essentially any noisy environment. This solution will have broad implications for health and quality of life for the estimated 30 million Americans with hearing loss.